National Practice Guidelines for Safe Tapering of Benzodiazepines

Abstract
Benzodiazepine medications are commonly prescribed to treat a wide range of conditions including
anxiety and mood disorders, insomnia, and seizure disorders. These medications represent important
therapeutic tools; however, they are associated with significant adverse events including potentially life-
threatening withdrawal, substance use disorder, and overdose (particularly when combined with alcohol,
opioids, or other central nervous system depressants). Over the past two decades, fatal overdoses
involving benzodiazepines have increased more than 10-fold, often involving the combination of opioids
and benzodiazepines.1 Benzodiazepine prescribing rates are highest2 for older adults, among whom these
medications pose additional risk for falls, hip fractures, and cognitive impairment.3 While there is little
research on the efficacy of benzodiazepine use for longer than three months and the risk for adverse
events increases with duration of use, long-term use is common.3 Despite the prevalence of prescribing
and the significance of the risks, there are currently no national clinical guidelines to inform clinicians in
determining when and how to taper benzodiazepine medications. Safe tapering of benzodiazepines can
be clinically complex since rapid dosage reductions may precipitate acute withdrawal, which can be life-
threatening. Patients are also at risk for recurrence and exacerbation of the symptoms for which the
benzodiazepine was prescribed (e.g., anxiety, seizures, insomnia). In addition, inadequate tapering
strategies may push patients to the illicit drug market where counterfeit pills laced with fentanyl and
other opioids are common, presenting a risk for overdose and overdose death.4 To support the FDA’s
goal of “safely reducing inappropriate prescribing of medications with potential for misuse and
dependence”, the American Society for Addiction Medicine (ASAM) will develop a clinical practice
guideline (CPG) to guide clinicians in determining when and how to taper benzodiazepine medications.
ASAM has significant expertise developing CPGs and established partnerships with other medical
societies with expertise relevant to this topic including the American Psychiatric Association, the
American Academy of Neurology, the American Society for Geriatrics, and the American College of
Gynecology and Obstetrics, among others. ASAM will work with these partners to convene an expert
panel with multidisciplinary medical expertise to develop a CPG using a modified GRADE methodology.
A systematic review of the evidence related to benzodiazepine tapering will be conducted to inform the
work of the expert panel. People with lived experience will be engaged throughout the process to ensure
that the CPG addresses patient concerns and needs. Once the guideline is complete, ASAM will work
with the FDA and our partners to widely disseminate the guidelines as well as training and clinical
decision support tools to facilitate improvements in benzodiazepine prescribing practices.

Public health relevance
Project Narrative Benzodiazepines are commonly prescribed for long-term use, with significant potential for adverse events including withdrawal, substance use disorder, falls, cognitive impairments, and overdose (particularly when combined with alcohol or opioids). National clinical practice guidelines are needed to inform clinicians in determining when and how to safely taper benzodiazepine medications.